Acquisition of a JEOL JEM-CRYOARM300

Abstract
This proposal is for the purchase of a 300 keV cryogenic-transmission electron microscope
(cryoTEM) to be housed in the CryoEM Core at the University of North Carolina at Chapel Hill
(UNC-CH). This cryoTEM, the JEOL CRYO Arm 300 II (JEM-3300), will serve as a multi-functional
instrument to support high resolution data collection for single particle (SP) cryoEM projects as
well as for cryo-electron tomography (cryoET) and micro electron diffraction (microED). Currently,
the UNC-CH CryoEM Core houses only a single 200 keV cryoTEM, yet the core still serves over
120 researchers representing 50 research groups. These researchers are located not only at
UNC-CH, but also at several nearby universities. The UNC CryoEM Core therefore serves as a
regional resource to those without cryoEM access and expertise. The addition of a JEM-3300 is
crucial for our core to have the capacity needed to support the already high, and continually
growing, demand from our NIH-funded user base. As the UNC-CH core has only a single
cryoTEM, we struggle to service all users in a timely fashion, even though our instrument is
maximizing its available usage time. Additionally, UNC-CH does not have a 300 keV instrument,
a prerequisite for performing high-resolution cryoET. The proposed instrument will therefore both
expand our throughput for collection of SP cryoEM data, while also expanding our capabilities to
perform cutting-edge cryoET and microED experiments. The JEM-3300 will support scientists
studying a wide range of research questions relevant to public health. Some of these questions
are fundamental, and address regulation of genomic processes, cell division, and exocytosis. Still
others address how the enzymes involved in lipid metabolism affect heart health, study the role
of amyloid fibrils in Alzheimer's disease, and address viral exosomes and their causative role in
cancer. These research questions are diverse but are united in their reliance on high-resolution
structural biology to answer mechanistic questions about cell biology. CryoEM has revolutionized
modern structural biology, and the new technology fueling this revolution allows researchers to
obtain high-resolution structural insights with unprecedented speed and resolution. These insights
will allow us to understand the etiology of multiple diseases and move towards therapeutic
solutions.

Public health relevance
Narrative We are seeking funds to acquire a JEOL CRYO ARM 300 II (JEM-3300) cryogenic transmission electron microscope that will enable us to uncover the 3-D structures of proteins and perform cryo-electron tomography on cells and organelles. The JEM-3300 will advance our ability to support the aims of over 20 NIH-funded research projects led by scientists at the University of North Carolina at Chapel Hill and our regional partners. High-resolution structures are a prerequisite of building molecular models of disease etiology and this instrument will therefore advance our understanding of, and cures for, a range of human pathologies including cancer, heart disease, infectious diseases, and neurological disorders.